Conference Series on Aging in the Americas

Abstract
The proposed third competing renewal application extends a successful Conference Series on Aging in the
Americas (CAA). Previous international-CAA (ICAA) installments have had a distinctive focus and each
resulted in peer-reviewed books and special journal issues as published on the CAA website. The next three
iterations at the University of Texas Medical Branch, Galveston, (2020), The University of Illinois, Chicago
(2021), and The University of California Los Angeles (2022), build upon the same very high quality of work at
previous meetings to address a new theme that is a priority for the national health agenda. This will be
accomplished by commissioning 36 papers, including six keynote speakers from sociology, psychology,
demography, social policy, medicine, gerontology, and economics to address three major goals: First, to
provide a vehicle for reviewing and analyzing the contemporary social science research on “resilience,” the
major dimensions of which are physical, cultural and economic as it relates to enhancing the health, wellbeing
and function of aging Latinos in midlife and beyond; and second, to further the development of emerging
scholars through their increased exposure to this body of knowledge, developing their individual research, and
career mentoring. The ultimate objective of the series is to explore new science and applications of resilience;
provide mentoring resources to help emerging scholars develop research program on resilience, serve as a
catalyst for developing bi-national collaborative projects; and promote opportunities to use NIA data bases.

Public health relevance
Project Narrative This application describes a series consisting of three new installments of the Conference Series on Aging in the Americas (CAA) otherwise known as ICAA will examine how resilience, variously defined and operationalized, affects social and behavioral pathways that strengthen health and foster well-being of older Latinos in Mexico and the United States.